Antifibrotic effects of Syndecan-2 and CD148 in Rheumatoid Arthritis Interstitial Lung Disease

Project Summary/Abstract:
This K01 proposal describes a five-year research and training plan that will facilitate the transition of Dr.
Konstantin Tsoyi to an independent academic researcher in the field of rheumatoid arthritis-associated interstitial
lung disease (RA-ILD). Dr. Tsoyi has a strong background in molecular biology and pharmacology and has
completed post-doctoral training in immunology and lung fibrosis. RA is a systemic inflammatory disorder
affecting approximately 3 million people in the United States. ILD is the most common lung complication of RA
and is associated with increased mortality. RA-ILD occurs in approximately 10% of patients with advanced RA,
and another 30% with early disease, half of whom will progress. Little is known about the molecular mechanisms
involved in the pathogenesis of RA- ILD. The current application endeavors to create a niche of basic and
translational investigation to better understand the role of fibroblasts, in the pathophysiology of RA-ILD with the
ultimate goal of developing therapeutic interventions.
The candidate has previously demonstrated the antifibrotic properties of syndecan-2 (SDC2), a member
of the heparan sulfate proteoglycan family, in an animal model of radiation-induced pulmonary fibrosis. The
overarching aim of this proposal is to delineate the role of SDC2 in a model of RA-ILD using in vivo and in vitro
approaches. The applicant hypothesizes that SDC2 deficiency increases susceptibility to experimental lung
fibrosis in an established arthritis murine model. Furthermore, SDC2 exerts antifibrotic effects by
activating CD148 (a membrane-bound protein tyrosine phosphatase) and reducing PI3K/Akt/Sp1
signaling and peptidylarginine deiminase-2 (PAD2) expression in lung fibroblasts. The significance of this
research is that knowledge gained from this study will contribute to the development of future therapeutics for
patients affected with RA-ILD.
Dr. Tsoyi will receive mentorship from his scholarship oversight committee, composed of distinguished
scientists with expertise related to key areas of this proposal, including lung fibrosis, RA and fibroblast biology.
The training opportunities and resources at Brigham and Women’s Hospital (BWH) and Harvard Medical School
(HMS) provide an ideal environment for the candidate’s career development. The Department of Medicine at
BWH is committed to Dr. Tsoyi’s success and has assured 100% protected time to devote to the activities
described in this proposal. The candidate’s mentors, Drs. Ivan Rosas and Michael Brenner, are NIH-funded
investigators and leaders in the fields of interstitial lung disease and rheumatoid arthritis. This application outlines
a detailed career development and training plan that includes the proposed mentored research, didactic
coursework, self-directed readings, seminars, and presentations at scientific meetings. The expertise and
knowledge gained from this K01 will enable Dr. Tsoyi to obtain R01 funding to launch an independent research
career focused on the study of molecular mechanisms involved in the development of RA-ILD.

Public health relevance
Project Narrative: Rheumatoid arthritis (RA) is a systemic inflammatory disorder affecting approximately 3 million adults in the United States; interstitial lung disease (ILD), particularly pulmonary fibrosis, is the most common lung complication of RA and is associated with increased mortality. This study aims to define how syndecan-2 (SDC2), an antifibrotic proteoglycan, affects the development of lung fibrosis in the setting of arthritis. The results of this work will provide a better understanding of the molecular mechanisms driving the pathogenesis of RA-associated lung fibrosis and identify potential therapeutic targets to treat patients with this progressive disease.